The Carolina Endometrial Cancer Study: A population-based survivor cohort

ABSTRACT
Endometrial cancer is the 4th most common cancer diagnosed and 6th leading cause of cancer death among
United States (U.S.) women. Today, there are more than 891,000 endometrial cancer survivors in the U.S.,
making it the second largest cancer survivor group among women (after breast). Black women are more likely
than White women to have endometrial cancer recur and are twice as likely to die. Disparities in endometrial
cancer outcomes are multifactorial; contributors likely include, but are not limited to, an inequitable distribution
of worse-prognosis biologic subtypes, variation in symptom recognition and receipt of guideline-concordant
cancer treatment, and differential survivorship care. We propose a comprehensive approach to understand
underlying racial disparities in outcomes within a population-based endometrial cancer survivorship cohort. The
Carolina Endometrial Cancer Study (CECS) will prospectively recruit women with newly-diagnosed endometrial
cancer in North Carolina using the statewide Central Cancer Registry’s rapid case ascertainment program.
Black women will be oversampled by design in order to enroll ~667 Black women within the planned cohort of
~1,700 women. Baseline data collection includes retrieval of tumor paraffin blocks and medical records for
detailed diagnostic and treatment history, collection of buccal samples, and administration of questionnaires
offered in written, phone, or online formats. We will conduct follow-up interviews every 18 months and retrieve
medical records for any additional endometrial cancer treatment or reported disease recurrence. Our aims
include: 1) To assess variation in the distribution of endometrial cancer histologic and molecular subtypes that
are associated with poor prognosis among Black and White women evaluated by centralized pathology review;
2) To assess variation in presenting symptoms and receipt of guideline-concordant endometrial cancer
treatment among Black and White women and; 3) To assess variation in experience and provider assessment
of guideline-recommended symptoms for surveillance visits and survivorship care among Black and White
women. The proposed cancer epidemiology survivorship cohort uses a population-based platform and
combines detailed tumor biology and patient-reported survey data to investigate endometrial cancer biology,
medical care, and experience. We collect detailed information on individual-level molecular tumor
characteristics; behavioral and lifestyle factors; cancer treatment, follow-up care, and recurrence information
abstracted from medical records; and have an established infrastructure to link participant records to
administrative insurance claims and area-level social determinants of health and health system factors. The
multidisciplinary investigative team and patient advocacy support facilitate investigation of not only the
proposed aims, but create a resource and infrastructure for ongoing research to advance the science of
endometrial cancer survivorship.

Public health relevance
NARRATIVE More than 891,000 U.S. women have an endometrial cancer history, making it the second largest cancer survivor group among women. Racial disparities have been reported across the endometrial cancer continuum—from recognition of symptoms leading to diagnosis through receipt of guideline recommended cancer therapy and survivorship care. The Carolina Endometrial Cancer Study is a diverse, population-based cancer epidemiology survivor cohort that collects detailed information on novel molecular characteristics; medical history; cancer treatment and follow-up care; individual- and contextual-level social determinants of health; and behavioral and lifestyle factors to advance our understanding of endometrial cancer survivorship.